Improving seated postural control and upper extremity function in bilateral CP with a robotic Trunk-Support-Trainer (TruST)

Project Summary/Abstract
Children with moderate-to-severe bilateral cerebral palsy (CP) have poor trunk and upper limb
control which negatively impacts their participation in leisure and educational activities. Activity-
oriented training of skilled upper limb motor tasks with appropriate task progression has been
shown to be effective for recovery of upper limb and postural control.
We have previously shown that robotically applied assistance at the trunk helps children
with CP gain independent sitting and improve head-trunk-arm coordination. This proposal seeks
to develop and test complex virtual tasks, displayed on a screen or a head-mounted virtual
reality display, that are specifically designed to train postural control and upper limb movements.
The tasks will be integrated into training with our robotic trunk support platform. These tasks will
be carefully designed to be highly repeatable, scalable, and allow for analysis of variability in
movements and how this variability affects performance. Motor variability and its changes are
closely linked to motor strategy selection, skill acquisition, and motor learning. The results will
be used to explore the effect of robotic postural assistance and task practice on postural and
upper limb task performance, movement variability, and performance improvements.
Complex postural and upper limb tasks that allow the child flexibility in accomplishing the
task are often used by physical therapists to train motor skills but are hard to analyze. Examples
include ball throwing and catching, reaching to a moving target, and block stacking. The
developed virtual tasks will allow study of how children with CP perform these tasks with
different kinds of postural assistance and over time. The results will provide insight on how
postural control influences upper limb function and how motor learning of new upper limb tasks
occurs with practice in CP. These findings could point to new assistive and training strategies to
promote recovery of function.
The first aim of this proposal is to develop these virtual postural and upper limb training
tasks and explore how robotic postural assistance affects performance in healthy adult subjects
and children with CP. The second aim is to study how healthy adults and children with CP
improve their postural control and upper arm movements with practice of these tasks in a multi-
session training. Dr. Sunil Agrawal, an expert in rehabilitation robotics, Dr. Victor Santamaria, a
physical therapist and experienced postural control researcher, and Dr. Jason Carmel, a
neurologist and neuroscientist, will provide guidance and mentorship on the project.

Public health relevance
Project Narrative We propose developing training tasks in virtual environments, such as virtual reality, that train both posture and upper limb movements and enable the study of motor variability and strategy in these movements. We will use them to explore how robotic support of posture can affect upper limb movement, to train posture and upper limb movement, and to study how children with CP improve in these tasks with training. The results could lead to new insights on how children with CP coordinate posture and upper arm movement, how they learn to improve these movements with practice, and new training strategies to promote improved posture and upper limb function.